Revitalization and upgrade of cyclotron

Project Summary
The Martinos Center at Massachusetts General Hospital (MGH) boasts a dynamic simultaneous magnetic
resonance and positron emission tomography (MR-PET) imaging program. This program supports a substantial
community of NIH-funded investigators, facilitates clinical trials, and offers crucial shared resources to the
Institute for Innovation in Imaging (i3) and Interdepartmental Brain Center (IBC) at MGH. In 2010, an 11 MeV
medical cyclotron was installed at MGH's Charlestown campus to bolster radiochemistry and translational
radiotracer development and manufacturing. This cyclotron primarily produces short-lived imaging isotopes using
carbon-11 and fluorine-18. The Siemens Eclipse HP cyclotron infrastructure lies at the heart of the research
imaging enterprise. After 13 years of service, a reinvestment is necessary to ensure continued access to PET
radioisotopes for the MGH Charlestown campus. Instead of replacing the Siemens Eclipse HP, which would
result in significant operational disruption and research downtime, we propose a series of upgrades extending
the cyclotron's lifespan by 10-15 years. These upgrades will stabilize maintenance-related operational elements,
modernize the control software, and expand radiotracer production capacity. Furthermore, the upgrades will
introduce new solid target capabilities to support the user community currently sourcing and shipping copper-64
from over a thousand miles away, thus establishing a Boston-wide source for the radioisotope. A current snapshot
reveals 9 major and 19 minor users that will be positively impacted through funding this shared instrument grant
application and the subsequent upgrades, but we also note that more than 60 human study protocols (3860
human imaging experiments) and more than 30 preclinical studies (675 non-human primate and >5000 rodent
experiments) have relied on the cyclotron to date. With the volume of scanning growing, this SIG funding will
support an extraordinarily strong scientific community. Specifically, we propose upgrading the RF system,
software and control computers, vacuum system, and adding a solid target to one of the beam lines. This cost-
effective, practical plan will ensure that NIH-funded investigators maintain a reliable supply of PET radioisotopes
and radiotracers essential for their research.

Public health relevance
Project Narrative The Martinos Center at MGH requires reinvestment in its Siemens Eclipse HP cyclotron infrastructure to ensure continued access to PET radioisotopes for its dynamic MR-PET imaging program. Instead of replacing the cyclotron, a series of upgrades will extend its lifespan by 10-15 years and support an extraordinarily strong and growing user community. This cost-effective plan will guarantee a reliable supply of radioisotopes and radiotracers for NIH-funded investigators' research and beyond.